Biological and structural diversity of bacterial type IV secretion systems

PROJECT SUMMARY
The transmission of macromolecules across biological membranes is a fundamental process in all cells. In the
earliest studies of genetic exchange in bacteria dating back to the 1940's, the F plasmid (then termed `sex
factor') was shown to self-transfer and, through recombination, mediate the transfer of the entire E. coli
chromosome to recipient bacteria. In the ensuing ~75 years, studies established the broad medical importance
of F and other mobile genetic elements (MGEs) in the shaping of bacterial genomes and as vectors for
dissemination of antibiotic resistance and other fitness traits among bacterial populations. MGEs also encode
conjugative pili or other cell surface adhesins, which promote intercellular contacts necessary for DNA transfer
and establishment robust, antibiotic-resistant biofilm communities. MGEs are transmitted intercellularly through
nanomachines termed type IV secretion systems (T4SSs). The T4SSs are present in most if not all bacterial
species, where they have functionally diversified into two large subfamilies, the DNA transfer or conjugation
systems and the `effector translocators' that translocate effector proteins into eukaryotic host cells as a critical
feature of infection processes. Over the past 27 years, my group has used molecular, genetic and biochemical
approaches to identify many mechanistic and architectural features of T4SSs, including the first view of the
translocation route for a DNA substrate through a T4SS. We have consistently implemented emerging
technologies, and just within the past 1½ years we began to solve T4SS structures at unprecedented
resolution by in situ cryoelectron tomography (CryoET). These new structures are significantly advancing the
field, but also are raising important new questions relating to underlying mechanisms and signals governing i)
assembly of envelope-spanning T4SS channels and conjugative pili, ii) early-stage substrate recruitment and
processing reactions, and iii) establishment of direct contacts (mating junctions) with bacterial and eukaryotic
cells. Moving forward, we will address these fundamental questions by (1) continuing to solve novel structures
encoded by the E. coli F T4SS using in situ CryoET, biochemical fractionation, super-resolution fluorescence
microscopy, and single-particle CryoEM, (2) defining contributions of the newly visualized ATPase energy
center positioned at the channel entrance in binding and unfolding substrates and dissociating accessory
factors using in vivo and in vitro biochemistry and ultrastructural approaches, (3) exploring the roles of
conjugative pili and cell surface adhesins in formation and disassembly of mating junctions using cytological,
biochemical and biophysical approaches, and (4) exploiting our development of distinct model systems to
identify mechanistic themes and specialized mechanisms. We will continue to draw on the expertise of our
close collaborations for a `team-science' and multidisciplinary focus. Our studies will generate important new
insights into the architecture, biogenesis, and mechanism of action of the T4SS superfamily. These findings
will lead to major paradigm shifts in this field, and set the stage for design of intervention therapies.

Public health relevance
PROJECT NARRATIVE The bacterial type IV secretion systems are widely used by many medically important pathogens for transfer of mobile genetic elements that harbor genes for antibiotic resistance. These secretion systems also elaborate pili and cell surface adhesins, which contribute to formation of robust biofilm communities that are resistant to antibiotic treatments. These systems also are deployed by many pathogens to deliver virulence factors into the human host to aid in infection processes. The type IV secretion systems are relevant for public health as they represent novel targets for therapeutics directed to blocking antibiotic resistance spread, production of robust biofilms, and disease progression.